PSORIASIS

Evaluation, treatment, referrals for treatment of psoriasis and psoriasiform dermatoses. Treatment of patients with extensive psoriasis who have not been responsive to conventional ambulatory treatment and for whom methotrexate, etretinate, PUVA, cyclosporine A and other modalities are contemplated. Immunological and molecular studies of patients' cells are monitored throughout therapy. Pilot studies mapping gene(s) for psoriasis. MOdes of treatment other than PUVA.